Uncovering incomplete penetrance genes in congenital heart disease by integrative analysis of Common Fund data

PROJECT SUMMARY
Congenital heart disease (CHD) is the most common birth defect and a leading cause of mortality in children.
Despite a well-established heritable componentto this disorder, genetic testingis often unsuccessful. Some 60%
of patients fail to receive a molecular diagnosis; for patients with isolated CHD, the failure rate is closer to 90%.
Without a precise diagnosis, it is difficult to provide any patient with an accurate prognosis or personalized
interventions. The main reason that diagnostic testing fails is that our knowledge of the genetic underpinnings of
CHD remains woefully incomplete. CHD is not only genetically heterogeneous, but also notorious for incomplete
penetrance (variants that do not always cause a condition). In this proposal we aim to quantify the role of
incomplete penetrance in CHD risk genes. We will source a large cohort of CHD families fromthe Gabriella Miller
Kids First resource, the Undiagnosed Disease Network, Genomics England, and an internal research study and
performtwo complementary analyses to rank CHD genes. First, we will apply a genetic association study of CHD
probands to prioritize genes with an increased burden of rare genetic variation among CHD patients irrespective
of the inheritance pattern. This will be achieved through an innovative new resource: a remote control database
of 40,000 healthy, diverse controls and a method to securely select matched controls for any given case cohort.
Second, we will performpedigreeanalysis of all CHD families to identify genes in which rare large-effect variants
segregate with disease. Finally, we will combine the results of both strategies into a single master table of CHD
genes and use the segregation patterns observed in all families to quantify the extent of incomplete penetrance.
We expect our results will serve as a reference for the diagnostic initiatives in CHD and will inform clinical
geneticists about the likelihood of disease causality for genes challenged by incomplete penetrance. Our results
should provide a framework for integrating association and segregation analyses that could be adapted to other
genetically heterogeneous conditions.

Public health relevance
PROJECT NARRATIVE Congenital heart disease (CHD) is a leading cause of death in children and often results in lifelong morbidity because its origins are poorly understood. Although CHD has a strong genetic component, current genetic tests for this condition have very low diagnostic success rates (~10%), which is a major barrier to improving clinical outcomes and prognosis. This project – which will use new integrative analyses of Common Fund data to uncover the genetic underpinnings of CHD -- thus aligns with the NIH mission of developing targeted prevention strategies, treatments, and cures.